Integrin alphaIIbbeta3 Structure, Activation, and Ligand Binding

DESCRIPTION (provided by applicant): Platelets play a central role in both hemostasis and thrombosis, and contribute to a wide range of related phenomena, including inflammation and metastasis formation. The ultimate goal of this grant proposal is to understanding the way in which platelets interact with the blood vessel wall and with other platelets via the glycoprotein receptors on their surface, and to use that knowledge to improve human health. Despite advances in analyzing the structure and function of the αIIbβ3 receptor, which is crucial for normal hemostasis and a validated target of antithrombotic therapy, major gaps remain in understanding ligand binding and its impact on platelet physiology. Moreover, there is a need for improved potent antiplatelet therapies that cn be administered in the pre-hospital phase of myocardial infarction. The data obtained from these studies will inform attempts to develop novel inhibitors of αIIbβ3 that have therapeutic advantages over existing agents. In Specific Aim 1 we propose to improve our understanding of ligand binding by: a) Using functional ligand binding data and new crystal structures of αIIbβ3 as inputs to state-of-the art computational methods to identify interactions between the fibrinogen γ-module and αIIbβ3 in addition to those made by the fibrinogen γ-chain C-terminal dodecapeptide (γC-12), b) Using electron cryomicroscopy (cryo-EM) and negative stain EM in conjunction with random conical tilt reconstructions, molecular dynamics (MD)-based flexible fitting and steered MD to obtain atomic resolution 3-dimensional (3D) representations of intact αIIbβ3 in a nanodisc lipid bilayer in the absence of detergent. The inactive receptor, the receptor activated by talin head-domain (THD) in the absence of ligand, and THD-activated receptor in the presence of fibrinogen will each be studied. c) Using zinc finger nuclease-mediated gene editing to evaluate mutations of β3 in murine platelets rather than in cell lines that lack the platelet's signaling machinery, focusing initially on a mutation we hypothesize will enhance the binding of filamin to the β3 cytoplasmic tail and thus diminish platelet sensitivity to activation. d) Using enhanced MD techniques to characterize αIIbβ3 activation pathways and testing the hypothesis that the new αIIbβ3 antagonists identified in the past grant period (RUC-1, RUC-2, MSSM-1, MSSM-2) stabilize a closed, inactive conformation, thus accounting for their reduced ability to activate αIIbβ3 compared to αIIbβ3 antagonists patterned on the Arg-Gly-Asp (RGD) cell recognition sequence. In Specific Aim 2 we propose to identify new compounds that will provide insights into αIIbβ3 structure-function and may have therapeutic potential by characterizing the 57 compounds (out of 126,000 tested) that most potently inhibit αIIbβ3-mediated platelet adhesion and aggregation. We will also perform a new screen to selectively identify compounds that target ancillary fibrinogen binding sites since these may lead to new therapeutics that are safer and more efficacious.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this project is to understand the mechanism underlying the function of human blood platelets, which are vital in preventing bleedin, but also contribute to thrombotic disorders such as heart attacks and stroke. By studying one of the platelet's key molecules, the receptor αIIbβ3, at the atomic level both functionally and by computer simulations, we hope to obtain insights into platelet function and the function of other receptors in the same family. Finally, using new high throughpt technology, we hope to identify new compounds that may form the basis of improved therapies for heart attack and stroke.